Intervention Core - Improving Provider Announcement Communication Training (IMPACT)

The Intervention Core will support the proposed Program Project, “Improving Provider Announcement Communication Training (IMPACT)” with the goal of improving health care use. The Intervention Core will synthesize project-specific findings regarding the implementation and effectiveness of standing orders support (Project 1), financial incentives (Project 2), and clinical champions (Project 3) into the Announcement Approach Training (AAT) Intervention Package. AAT is a brief communication workshop that helps primary care teams improve the way they recommend primary care and address parents' concerns. In a prior randomized clinical trial, AAT increased primary care use over the control within just 3 months. The proposed Program Project seeks to amplify AAT's impact by combining it with the interventions to be tested in Projects 1-3. The Program Project will then compare the population impact and cost-effectiveness of these interventions, including in rural areas (Project 4). The Intervention Core will support the four research projects in the P01 to maximize the quality and comparability of AAT interventions delivered and evaluated over the 5-year study period. Aim 1 is to convene a Clinical Advisory Board to provide projects with multi-disciplinary implementation support. Our board includes leaders in pediatrics, family medicine, nursing, and quality improvement. Through quarterly meetings, the board will support the development of intervention materials, the recruitment and retention of clinical sites, and the interpretation and dissemination of study findings. Aim 2 is to prepare AAT facilitators and training materials for intervention delivery. To achieve the highest-quality interventions, we will centralize (1) the training of the facilitators who will deliver our AAT workshops to primary care teams and (2) the preparation of intervention materials. Aim 3 is to harmonize assessment of implementation measures, including cost. The Intervention Core will monitor the quality of implementation data collected in Projects 1-3 to ensure timeliness, completeness, and accuracy. This quality monitoring will support the successful completion of Project 4's cost-effectiveness analyses and other information for the AAT Intervention Guide. Aim 4 is to facilitate the national dissemination of study findings and intervention materials. Collaborating with Projects 1-4, the Intervention Core will disseminate study deliverables to audiences in academia, clinical practice, and public health. Most notably, the Core will lead the production of the AAT Implementation Guide for use in healthcare systems. In sum, the Intervention Core will be instrumental to the Program Project's goals of improving primary care teams' communication, increasing health care use, and ensuring that today's youth have the highest level of health. The Intervention Core addresses the IMPACT Program Project theme by building capacity for clinical communication interventions among primary care teams in healthcare systems.

Public health relevance
The Intervention Core will support the efforts of 4 research projects to conduct high-quality evaluations of Announcement Approach Training interventions. We will accomplish this goal by coordinating clinical expertise, preparing training materials and facilitators, harmonizing key measures, and sharing study products.